Training in Myocardial Biology at Stanford

PROJECT SUMMARY/ABSTRACT
The Stanford University School of Medicine is a research-intensive medical school with a rich history of
innovation and translation of biomedical science from the bench to the bedside. This is the second competing
renewal for the Training Program in Myocardial Biology at Stanford (TIMBS). Our diverse program faculty are
drawn from departments at Stanford across many disciplines, and represent world renowned experts in their
chosen domains. The cohesion of this group, which includes physiologists, molecular biologists, engineers,
geneticists, and cardiologists has been fostered by the principal investigators in an environment which has for
decades placed a high value on multi-disciplinary collaboration. Close co-localization of basic science
departments and bioengineering with the school of medicine and brand new adult and pediatric hospitals
facilitates great synergy and a culture of innovation and translation. Although still relatively young, the TIMBS
program has over the last nine years already established itself as an important venue for the training of post-
doctoral fellows. The success of our initial trainees in obtaining grants and faculty positions, even at this early
stage, is testament to the talent of the applicants, the training provided, and the priority given the program by
the principal investigator mentors and faculty. This renewal application underscores and seeks to build on this
proven success. In particular, we reaffirm our commitment to rigorous scientific training by offering a period of
up to three years of protected time for research. The commitment begins with a ‘mentored’ recruitment process
with a special emphasis on enhacing diversity, continues with a comprehensive approach to learning the
scientific method with opportunities ranging from dedicated training seminars to a ‘visiting internship’, extensive
mentor-trainee interaction, and a comprehensive series of lectures and courses, including biostatistics, the
responsible conduct of research, and rigor and reproducibility, as well as our highly successful grant writing
academy specifically targeted to K award applicants. Our commitment extends well beyond the completion of
the funded period with programs for career development, assistance and advice to ensure our trainees’
success as they enter into full time academic positions. Our aim is to mentor the next more diverse generation
of leaders in myocardial biology. Our obligation extends until our trainees fulfill this goal and beyond.

Public health relevance
NARRATIVE Heart failure affects 5 million American adults and children and accounts for more hospitalizations than all forms of cancer combined. This training program aims to provide a rigorous training, emphasizing cross- disciplinary collaboration, in the science of heart muscle health and disease for a diverse group of post- doctoral scholars whose goal is a career of investigation in science or medicine.